Harnessing Atropisomerism in beta-Carbolines for the Discovery of New Reactions and Small Molecule Probes

Project Summary
New therapeutics that have potential for treating disease are among the public health goals that are central
to the mission of the NIH. While traditional strategies have had remarkable success, molecules with novel
structures and new modes of action are still needed to serve as drug leads. In this work, we wish to study the
unique stereochemical property of small molecules known as atropisomerism. Chiral molecules with an
atropisomeric axis, once seen by the scientific community as too risky for development, are now becoming
increasingly common in drug discovery and medicinal chemistry because of improvements made to compound
potency, selectivity, stability, and pharmacokinetics. In this proposal, our team of undergraduate student
researchers at Providence College will continue to shift the paradigm by exploiting stable atropisomerism in the
nitrogen-containing heterocycle known as the β-carboline. We have identified 1-aryl-substituted-β-carbolines
with antibacterial, neuropharmacological, and DNA-binding activity, which make them appropriate for study
through the National Institute of General Medical Sciences. Our main focus is on the atropisomeric behavior of
1-aryl-substituted-β-carbolines, in which we have observed barriers to rotation greater than 30 kcal/mol. Given
the remarkable configurational stability of these molecules, we will establish three new strategies for harnessing
their potential as chiral molecules for improving human health and well-being. Our first goal will be to develop a
kinetic resolution strategy for rapidly accessing the individual enantiomers of 1-aryl-substituted-β-carbolines. We
will use β-turn peptides to perform an asymmetric N-oxidation of these molecules, work which will be aided by a
continuing collaboration with colleagues at Yale University in the laboratory of Professor Scott Miller. The second
goal of the project will be the synthesis of the natural product chaetogline F, a β-carboline natural product with
known inhibitory activity of acetylcholinesterase. We will prepare the natural product, resolve the enantiomers,
and perform a structure-activity relationship study of this molecule which will shed light on the importance of
atropisomerism in target binding. The third goal is to develop a new asymmetric N,P-ligand based on the β-
carboline scaffold. We will synthesize the new ligand via a cross-coupling strategy and then assess its ability to
induce asymmetry in the synthesis of neuroactive alkaloids via alkyne additions to iminium ions. Finally, this
proposal will expose undergraduate students at Providence College to impactful research, which will both
improve the culture of scientific inquiry in a liberal arts setting and inspire students to continue in a STEM or
health-related field upon graduation.

Public health relevance
Public Health Relevance Our research program focuses on the development of new methods to exploit a property in small molecules known as atropisomerism. Atropisomerism is a form of molecular handedness that is becoming increasingly common in drug discovery and development since it can afford improved potency and selectivity, thus leading to safer therapeutics. Our work will develop new tools for accessing these structures, studying their behavior in chemical reactions, and assessing their potential to treat disease.